FOXL1 positive telocytes in intestinal development and homeostsis

FOXL1 positive telocytes in intestinal development and homeostasis
Abstract
The intestinal stem cell niche plays an essential role in enabling the self-renewal of the columnar
gut epithelium, a process that occurs continuously throughout life. Over the past five years we
have established that subepithelial fibroblasts resembling telocytes that express the DNA-binding
transcription factor Foxl1 are a critical component of the intestinal stem cell niche. Removal of
Wnt signals emanating from Foxl1+ cells or elimination of these specialized cells themselves
causes cessation of epithelial proliferation, crypt failure, and rapid death of mutant mice. In
addition, Foxl1+ cells demarcate critical signaling centers during intestinal development, and Foxl1
itself is required for villus development in fetal life. Based on these exciting findings, we have
built several crucial tools to further explore the function of Foxl1+ telocytes and fetal telocyte
precursors in three independent but interrelated specific aims. In specific aim 1, we will ablate
critical components of the planar cell polarity pathway in Foxl1+ telocyte precursors to determine
their contribution to villus formation during the epithelial transition in midgestation, based on our
findings from single cell RNAseq analysis that these factors are highly enriched in the Foxl1+
telocyte progenitor populations during villus formation, and the fact that villification is abnormal in
Foxl1 null embryos. In specific aim 2, we will test the hypothesis that the closely linked Foxl1 and
Foxf1 genes function cooperatively in telocytes or their progenitors to control both gut
development and the function of the adult stem cell niche. We will employ an innovative ‘double
floxed’ mutant allele to ablate both genes simultaneously in the Foxl1+ lineage and analyze fetal
gut development and adult tissue homeostasis using histology, immuno-staining, and molecular
assays. Finally, based on our discovery that GLP-2R, the receptor for the intestinal mitogen GLP-
2, and its downstream signal IGF1 are highly enriched in Foxl1+ telocytes, we will test the
hypothesis that telocytes are the GLP-2 target cell using inducible conditional gene ablation of
both Glp2r and Igf1 and evaluate GLP-2 action in multiple paradigms. Together, these linked yet
independent aims will dramatically increase our understanding of intestinal telocyte biology, a cell
type we have shown to be a critical component of the intestinal stem cell niche.

Public health relevance
FOXL1 positive telocytes in intestinal development and homeostasis Narrative Diseases of the gastrointestinal tract including inflammatory bowel disease and colon cancer represent serious health problems in the United States. Self-renewal of the gut lining throughout life is dependent on specialized niche cells that support the division of gut stem cells. Here, we will identify genes and pathways that control niche cell biology that might be targeted in the future for better treatment of diseases of the alimentary tract.